Bioorthogonal temporospatial tools - Admin Supple Equipment

Living systems choreograph molecular events with precise control—place, time, kinetics, and intensity
—and record memories of those occurrences in synaptic networks, gene expression, epigenetic
marks, and myriad other circuits that govern the where&when of biologic responses. Visualizing this
choreography and tracing these histories are tasks that chemists and biologists can accomplish with
only partial accuracy, considerable eﬀort, and limited temporal range. Our research agendas are thus
focused on constructing new chemical tools for temporospatial analysis of living systems, and
organized around the emergent properties that result from deploying next-level bioorthogonal
chemistries within multi-layered (bio)molecular architectures. The resulting hybrid systems circumvent
perennial challenges, achieving: i) simultaneous speed/stability, for eﬃcient real-time molecular
machinery and longitudinal performance in vivo; ii) sensitivity for detection of rare/unique events; and
iii) speciﬁcity/multiplicity, for accurate detection and ﬁne-grained molecular encoding of (sub)cellular
histories across time.
Building on the momentum of ongoing mechanistic investigations and the success of our recent eﬀort
to achieve multiplexed imaging of living cells and tissues, our goals for the next ﬁve years extend
bioorthogonal chemistry in applications that exploit two/three dimensional topologies, rather than
singular ligation/cleavage events, and in architectures that leverage nucleic acid hybridization to
encode sequence recognition, accelerate reaction kinetics, and enable signal ampliﬁcation. In one set
of projects, we aim to create self-amplifying programmable bioorthogonal reactions, elaborate the
capabilities of this new toolkit, and apply them to transform our methods for visualizing living cells and
tissues. In another, we have envisioned sequence-generating architectures that convert biocompatible
chemical reactivity into ampliﬁable biological information, establishing the concepts of bioorthogonal
translation and sequegenicity. With scaﬀolds that readily integrate into the workﬂows of existing high-
performance nucleic acid biotechnologies, we anticipate broad applicability and rapid downstream
development of a new generation of tools for tracking (bio)molecules, individual cells, and populations.

Public health relevance
We seek to construct biocompatible chemical tools that can interrogate the dynamic molecular events of living systems across space and time. By embedding highly eﬃcient reactions within 2D/3D nucleic acid scaﬀolds, we will build toolkits with the speed and sensitivity to capture the deep complexity of living cells and tissues. With architectures that can translate chemical events into new sequence information, we aim to erase boundaries between in vivo chemistry and nucleic acid biotechnologies, transforming (bio)molecular tracking and sensing.